Decoding cell surface chemistry and function in Staphylococcus aureus

PROJECT SUMMARY
Bacteria are essential to human health and also one of our greatest threats. Bacteria in the microbiome
facilitate gut health and prevent proliferation of unwanted organisms. However, pathogenic bacteria damage
tissues and enmesh themselves in communities termed bioﬁlms that evade antimicrobials and host defenses.
The unique chemistries at the bacterial cell surface and the biomolecules and polymers displayed and
released by bacteria inﬂuence how they engage with their surroundings and underlie the difference between
friend and foe in human health and disease. Staphylococcus aureus is a major Gram-positive organism
commonly residing harmlessly on the skin and in nasal passages and is a hallmark model organism used to
study cell walls and antibiotic modes of action, yet also emerges as a devastating pathogen in difﬁcult-to-treat
and antibiotic-resistant infections. This MIRA research program involves three bold and synergistic projects
to tackle outstanding molecular questions and decode S. aureus chemistry that distinguishes friend from foe,
that underlies bioﬁlm formation and sensitivity to antibiotics, and that inﬂuences interactions with other cells
and the host. We will implement and expand the unconventional and uniquely enabling cross-disciplinary
experimental platform, expertise, and instrumentation we have developed in our laboratory over the last 16
years to illuminate and quantify crucial molecules, bonds, and chemical modiﬁcations that have been
implicated in virulence and antimicrobial resistance, yet are in molecular blind spots for conventional
approaches. In prior work with common E. coli bioﬁlms, our unique approach uncovered a chemical structure
never before observed in nature that underlies bioﬁlm function and evaded detection for decades - a
chemically modiﬁed form of cellulose. In one thrust of this MIRA, we will integrate whole-cell NMR with
biochemistry and microscopy to generate blueprints for peptidoglycan and teichoic acid polymer changes as
S. aureus stealthily reprograms cell walls in bioﬁlms and persister cells, including teichoic modiﬁcations
implicated in virulence. We seek to establish likely relationships with antibiotic efﬁcacy and resistance,
including consideration of vancomycin conjugates we designed to interact with cell-surface anions that exhibit
extraordinary activity in eradicating bioﬁlm bacteria. In the second area, we will introduce labeling and
spectroscopic detection methods and detect atomic-level contacts between whole-cell teichoic acids and
proteins and peptides speculated to engage with teichoic acids. In the third area, we will deﬁne bioﬁlm
extracellular matrix composition among S. aureus to understand how they build multicellular architectures,
using our powerfully integrated biochemistry, proteomics, transcriptomics, microscopy, and solid-state NMR
approach. This MIRA program will yield fundamental and translationally relevant discoveries and introduce
broadly applicable strategies as many important cell-surface functions are achieved by polysaccharides,
glycoconjugates, and heterogeneous, insoluble assemblies.

Public health relevance
PROJECT NARRATIVE Bacteria are essential to human health and also one of our greatest threats when they emerge as devastating pathogens in difﬁcult-to-treat and antibiotic-resistant infections. This MIRA program deploys an unconventional and uniquely enabling cross-disciplinary experimental platform to decode the underlying cell- surface chemistry in Staphylococcus aureus that distinguishes friend from foe and underlies bioﬁlm formation and sensitivity to antibiotics to ultimately drive the development of urgently needed new anti-infective strategies. This program will yield fundamental and translationally relevant discoveries and introduce broadly applicable strategies as many important cell-surface functions are achieved by polysaccharides, glycoconjugates, and heterogeneous, insoluble assemblies.